The Role of Ariadne RBR E3 ubiquitin protein ligase 2 (ARIH2) in influenza A virus replication and pathogenesis in the airway epithelial cells

PROJECT SUMMARY
Influenza A viruses (IAV) pose significant global health threats, causing annual epidemics with substantial
morbidity and mortality. The prevailing resistance of the majority of H1N1 and H3N2 strains to antiviral drugs,
coupled with the emergence of the highly pathogenic avian H5N1 IAV that has breached species barriers to
infect humans, underscores the urgent need for a paradigm shift towards identifying drugs effective across a
spectrum of viral strains. The airway epithelium is the primary site for IAV replication. Our prior investigations
have highlighted the host cellular protein BIK as a pivotal player in IAV replication within airway epithelial cells
(AECs), influencing disease severity in humans. BIK deficiency impedes, while its overexpression exacerbates
viral replication, virus-induced lung inflammation, and mortality. Additionally, we have identified a single
nucleotide polymorphism in the BIK gene associated with influenza severity. IAVs facilitate their replication in
AECs by stabilizing BIK protein through inhibiting proteasomal BIK degradation. Our mass spectrometry analysis
has unveiled a novel BIK-interacting E3 ligase, Ariadne RBR E3 ubiquitin protein ligase 2 (ARIH2), which is
inhibited by IAV to stabilize BIK. ARIH2 depletion enhances BIK levels and viral replication, while its expression
reduces both, identifying ARIH2 as a novel IAV restriction factor exploited by the virus. Our proposal aims to
elucidate how IAV manipulates ARIH2 to inhibit proteasome-mediated degradation of BIK, thereby promoting
viral replication. We will test the central hypothesis that IAV nucleoprotein (NP) inhibits ARIH2 to block the
ubiquitin-dependent degradation of BIK, thereby promoting viral replication. Conversely, ARIH2 mitigates viral
burden in AECs by directing BIK towards proteasome-mediated degradation. To test this hypothesis, we
proposed three Specific Aims. Aim 1 investigates how IAVs exploit ARIH2 to Inhibit BIK degradation and promote
viral replication in the AECs. This Aim focuses on identifying crucial ARIH2 domains and BIK lysine residues for
ubiquitination, exploring the impact of ARIH2-mediated BIK degradation on viral replication and inflammatory
responses. Aim 2 explores ARIH2's role in mitigating influenza disease progression in vivo. Aim 3 evaluates
ARIH2’s therapeutic potential in mitigating viral load and lung inflammation in normal human bronchial epithelial
cells and human Precision-Cut Lung Slices. The proposed studies may uncover ARIH2 as a universal and novel
target for treating influenza infections, offering therapeutic promise due to its enzymatic nature and potential
selectivity towards BIK. These studies will have profound translational implications and hold the potential to
enhance prevention and treatment strategies for emerging and reemerging influenza strains.

Public health relevance
PROJECT NARRATIVE The airway epithelium is the primary site for influenza A virus replication. We identified host cellular proteins critical for enhancing and mitigating viral replication in the airway epithelial cells. The proposed studies will elucidate the mechanisms by which these host proteins regulate IAV replication and inflammation in the lung, which can lead to new therapeutic targets to reduce IAV infection and disease severity in humans.